GENE SPECIFIC DNA REPAIR

Summary of work: In response to UV irradiation of mammalian cells, the protein proliferating cell nuclear antigen (PCNA) forms an insoluble complex with nuclear substructures. This complex can be detected by immunofluorescence and western blot analysis within 30 min after UV irradiation. We have studied the role of nucleotide excision repair (NER) and its subcomponent, transcription coupled repair (TCR), in PCNA complex formation. PCNA complex formation was studied in genetically related hamster cell lines that differ only in their capacity to perform NER. We find that efficient PCNA complex formation induced by UV irradiation is dependent on both the genome overall repair of 6-4 photoproducts and the TCR of pyrimidine dimers in hamster cells. Cells from individuals with the premature aging syndrome Cockayne syndrome (CS) are also deficient in the PCNA relocation, supporting other findings from this lab demonstrating a defect of base excision repair of oxidative DNA damage in CS cells. We have biochemically analyzed the role of PCNA in the DNA repair of oxidative DNA modifications. By biochemical fractionation of cell extracts we can directly show that PCNA participates in conjunction with replication protein A (RPA) in the repair process. We have evidence for a deficient base excision repair process in CS cells. The incision activity at 8-oxoG lesions is deficient and can be complemented by the transfection of the cells with the normal, wild type CS gene. Base excision repair has two components, lang patch or short patch repair. PCNA participates in the long patch repair process and we speculate that this component of the DNA repair pathways may be defective in CSWe have also investigated the DNA repair of photo lesions in the ribosomal DNA in relation to the RNA polymerase I transcription in the nucleoli using a combination of immunological and biochemical approaches. We find that the nucleoli are completely deficient in DNA repair despite the presence of abundant RNA pol I transcription foci. Gene specific repair assays showed that both cyclobutane pyrimidine dimers and 6-4 photoproducts are removed much less efficiently from the rDNA than from an endogenous, essential gene. This observation is further substantiated by the analysis of repair kinetics of UV induced photolesions in the isolated BudR containing repair patches isolated immunologically using antibody to BudR. Immunological staining indicates that various NER proteins are absent in nucleoli, and this may be responsible for the inefficient repair of photoproducts in the rDNA.